Mechanisms of age-related tauopathy

ABSTRACT
In 2014, we proposed criteria for a new category of Alzheimer disease (AD) neuropathological change describing
subjects with AD-type neurofibrillary tangles without significant amyloid-beta (Aβ) deposition. This autopsy
designation, termed primary age-related tauopathy (PART), is the subject of increasing investigation, with studies
suggesting that PART diverges in important ways from AD. There is a critical need to better understand what
differentiates PART from other tauopathies and AD, which it mimics clinically and neuropathologically. We are
assembling a large collection of brain tissues from aged individuals to enable histopathological, genetic and
mechanistic molecular studies. We found that PART diverges pathoanatomically from other tauopathies with an
unexpected selective vulnerability of different hippocampal subfields. Our data indicates that PART has genetic
risk that partially overlaps with AD, uncovering an association with a locus on chromosome 4 containing JADE1,
a multifunctional adaptor protein that regulates cell death. Here, we will expand this work to derive novel
histopathological traits from our large collection to identify and validate additional risk alleles for PART and
uncover novel mechanisms. Our long-term goal is to elucidate the events that underlie tauopathy through
characterization of neurofibrillary changes on the cellular level for correlative clinical, biomarker, genetic, and
molecular studies. The objective here is to leverage our unique tissue collection to generate novel
pathoanatomical endophenotypes for functional genomic studies. We will deploy both classical and
computational histopathological approaches. Our preliminary data indicate that computationally derived features
more strongly predict functional impairment compared to the gold standard. Our central hypothesis is that
patients with PART have a distinct constellation of cellular and molecular drivers that converge with AD with
respect to tauopathy but diverge with respect to Aβ pathology. Our rationale is that better defining the
neuropathology of PART will enable clinical and genetic associations that reveal mechanistic insights into
neurofibrillary degeneration. We will accomplish our objectives by pursuing the following aims: Aim 1. To identify
neuropathological signatures of PART and lay the groundwork for genetic and mechanistic studies. Aim 2. To
identify risk alleles for PART. Aim 3. To test the hypothesis that candidate genes associated with PART play a
mechanistic role in neurofibrillary degeneration. This research is significant because better delineating the
features of PART in human post-mortem tissues will provide valuable insights into the cellular events associated
with tauopathies. This project is innovative because it will lead to improved approaches for diagnosis and staging
PART that more closely align with clinical symptomatology. This research represents a shift in the way we
conceptualize tauopathy in aging, allowing us to more fully define the neurofibrillary cascade, providing valuable
insights into the pathogenesis of tauopathies and paving the way towards novel biomarkers and therapeutics.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because we will transform the way clinicians and scientists classify individuals with Alzheimer’s disease neuropathologic change. Better defining the neuropathological signature of primary age-related tauopathy will lay the groundwork for mechanistic studies that will elucidate disease burden, pathogenesis and progression.